NCATS DPI TDB INFUSE HEALTH EQUITY PRECLINICAL DEVELOPMENT

The Health FFRDC Operator to provide independent, expert
technical, analytical, and subject matter support to conduct a survey of the rare disease
landscape, develop and identify best practices for infusing an equity perspective, and lay the
groundwork for a pilot of preclinical and therapeutics research into rare diseases with health
disparity implications.
The Health FFRDC will provide the timely integration and application of many disciplines and
functional specialties that are too broad and complex to acquire through individual, competitive
procurements with commercial contractors.

Public health relevance
Rare Diseases Research